Mechanistic and Therapeutic Studies using a Xenotransplanted RUNX1-Haploinsufficient Murine Model

ABSTRACT
Runt-related transcription factor 1 (RUNX1), is key to hematopoiesis. Insufficient levels of RUNX1 (RUNX1Lo)
results in familial platelet (Plt) disorder associated with myeloid malignancy (FPDMM), a rare disorder with
quantitative/qualitative Plt defects and an increased risk of leukemias. Understanding the basis of the Plt defects
and leukemic tendency, and developing therapeutics have been hampered by a lack of models that replicate the
human disease. For example, Runx1+/- mice have minimal defects in their Plts and do not demonstrate a
leukemic propensity. We and others have replicated the megakaryocyte (Mks, the cells from which Plts arise)
defect seen in FPDMM using human induced pluripotent stem cells (iPSCs), providing new insights into the Plt
defects. My group has extended this model using short-hairpin RNA (shRNA) technology in human CD34+-
hematopoietic stem and progenitor cells (HSPCs). The resulting Mks were studied in vitro and after infusion into
immunocompromised mice to release Plts in a xenotransfusion model. These studies confirmed and extended
the iPSC results; however, even the xenotransfusion studies are over a short window, limiting understanding of
the value of potential therapeutics on the Plt defects or the basis of leukemic transformation in FPDMM. To
address these needs, we are developing a RUNX1Lo human marrow xenotransplantation model in nonirradiated,
immunocompromised NOD,B6.SCID/Il2rg−/−KitW41/W41 (NBSGW) mice. Initial studies show that RUNX1Lo
HSPCs engraft as well as wildtype HSPCs in this model. We can detect RUNX1Lo Plts and myeloid/lymphoid
cells in the peripheral blood for >20 weeks post-injection. We now propose to complete the development of this
RUNX1Lo model by pursuing the following aims: Specific Aim (SA) #1: Characterize the molecular basis of
FPDMM in vivo. We will characterize RUNX1Lo HSPC engraftment, lineage commitment and Mk/Plt defects. We
will also examine mice for clonal evolution and malignant transformation with or without introducing a secondary
oncogenic stress to define the mechanistic of the leukemic propensity in FPDMM. SA#2: Perform in vivo drug
screening to reverse FPDMM pathobiology. Using the xenotransplant system developed and analyzed in
SA#1, we will carry out long-term drug exposure studies on the Mks/Plts defects, HSPC engraftment, lineage
commitment and on clonal evolution and leukemic transformation. At the moment, we have identified several
candidate drugs that partially or fully correct the Mk defect. RepSox, a small molecule transforming growth factor
receptor b1 inhibitor drug, corrects both Mk and Plt defects ,and dasatinib, a Src kinase inhibitor that may
increase RUNX1-specific activity, will be the first candidate drugs to be tested. Thus, we believe that within the
R03 timeframe, we will have established a RUNX1Lo xenotransplant model, developed new insights into the
mechanistic basis of the observed defects in FPDMM, and examined a series of potential therapeutics. These
advances will serve as preliminary data for external funding to support additional mechanistic and therapeutic
studies of RUNX1Lo as well as clinical therapeutic trials in patients with FPDMM.

Public health relevance
NARRATIVE We will make a mice model of a disease called FPDMM (familial platelet disease with myeloid malignancy), a disease inherited from one of their parents where there is a bleeding problem due to their platelets not working and also a high chance of developing leukemia early in life. The mice will have their bone marrow replaced with human bone marrow with this disease. We believe that studying these special mice will allow us to understand the platelet problem and the leukemia better and also allow us to test drugs that might prevent the disease FPDMM.